Transforming Training to Increase Diversity in the Tufts BIRCWH Program

Project Summary/Abstract
This proposed administrative supplement to the Tufts BIRCWH (K12HD092535-06) will be transformative in
increasing the diversity of the exceptional researchers in women's health and sex/gender differences with the
ultimate goal to better understand basic mechanisms of disease and develop treatment that addresses the
heterogeneity of treatment effects by sex. The Tufts University Building Interdisciplinary Research Careers in
Women's Health (BIRCWH) Scholars Program was recently renewed to continue a model program to recruit,
select, and train early career faculty to conduct basic research in sex/gender differences and clinical and health
services research on women's health issues. The long term goals of the Tufts BIRCWH Program are to
develop the next generation of leaders in research in sex/gender differences and women’s health. The
Program will fund faculty within six years of completing their training. For the additional scholar supported
through this administrative supplement, we propose to select from eligible candidates based upon disability or
from a group underrepresented in medicine and science who have completed their doctoral training but require
more in depth interdisciplinary research training. The Program will achieve its goals through five key activities,
tailored to meet each Scholar’s training needs: 1) interdisciplinary mentoring teams, 2) formal research
training, 3) interdisciplinary research seminars, 4) a mentored research project, and 5) development of skills in
grant proposal preparation. The addition of our BIRCWH DEI Director as part of the parent program will build
our existing capacity to advance the recruitment and retention of diverse scientists in the fields of women’s
health and sex and gender differences and advance inclusive excellence for all in the program.

Public health relevance
Project Narrative There is an urgent need to train a diverse group of investigators with an understanding of how to conduct research to understand the sex/gender differences in basic disease mechanisms and to understand the heterogeneity of treatment effects by sex/gender in devices, drugs, and other treatments. By leveraging the unique resources of the Tufts community, Dr. Freund and Dr. Jaffe have expanded the Tufts BIRCWH Program with Dr. Ndidiamaka Amatuh-Onukagha as DEI Director. This tailored training program ensures the training of a cadre of investigators to become the future research leaders in this critical area.